Path C The Continued Development and Implementation of the Connecticut Department of Agriculture Produce Safety Program Under Path C

Project Summary:
The Continued Development and Implementation of the Connecticut
Department of Agriculture Produce Safety Program Under Path C
This project is designed to successfully continue the development and implementation of the
Connecticut Department of Agriculture’s Produce Safety Program. The State of Connecticut is
seeking to advance the effort for Connecticut to be apart of a nationally integrated food safety
system through high quality consistent regulatory programs, education, and technical
assistance for producers.
To continue building our program, the Department is applying for funding under PATH C. Our
staff closely follow our strategic/project plan to implement the work of the program
throughout our State. All of our inspectors have been trained to inspect sprouts but at this
time there are no sprout growers in the State of Connecticut. Should there be a need to inspect
a grower in the future, inspections will be conducted under Subpart M of the Produce Safety
Rule, in conjunction with informing the FDA state liaison.
A comprehensive State web page for Connecticut’s Produce Safety program is found at: Fruit
and Vegetable Inspection Program Overview ( if hyper link does not connect—here is the link to
cut and paste) https://portal.ct.gov/DOAG/Regulatory/Regulatory/Fruit-and-Vegetable-
Inspection-Program-Overview
This website details Connecticut’s authority to enforce the Produce Safety Rule as a component
of the Food Safety Modernization act. It provides valuable information and insights for our
producers. Connecticut’s state statutes, cgs 22-39g, can be found here: Chapter 423 - Grading
and Marketing of Farm Products (state.ct.us)
(https://search.cga.state.ct.us/sur/chap_423.htm#sec_22-39g)
Under these statues, The Food, Drug and Cosmetic Act as amended by The Food Safety
Modernization Act, has been adopted by reference in our enabling legislation.

Public health relevance
Project Narrative: The Continued Development and Implementation of the Connecticut Department of Agriculture Produce Safety Program Under Path C is designed to successfully continue the development and implementation of the Connecticut Department of Agriculture’s Produce Safety Program. The State of Connecticut is seeking to advance the effort for Connecticut to be apart of a nationally integrated food safety system through high quality consistent regulatory programs, education, and technical assistance for producers.